University of Utah: The Road to Prevention of Stillbirth Clinical Research Center

PROJECT SUMMARY / ABSTRACT
Globally, millions of pregnancies per year end in stillbirth, which occurs in 5.48/1000 U.S births, exceeding
most high-resource countries and presenting major opportunities for improvement. Critical gaps in stillbirth risk
stratification hamper efforts to accurately target interventions. Moreover, significant inequities persist; for
example, American Indian/Alaska Native (AIAN) and Native Hawaiian/Pacific Islander (NHPI) people have 1.5-
2 times higher rates of stillbirth compared with White people. Further, stillbirth causes and experiences in AIAN
and NHPI communities remain poorly elucidated. The University of Utah (UofU) is an ideal site for the NICHD
“Road to Prevention of Stillbirth” Consortium, intended to reduce stillbirth in the U.S. For over 40 years, the
UofU has led one of the most productive U.S. stillbirth research programs, with one of the few clinical programs
dedicated to stillbirth prevention, staffed by leading experts with a history of national and global collaboration
with clinicians, scientists, parents, and community groups. We recently launched the UofU Stillbirth Center of
Excellence (USCoE), the first such center in the nation. With partners such as the University of Hawai’i,
Tséhootsoí Medical Center (Navajo Nation), and Australia’s Stillbirth Centre of Research Excellence, we are
poised to make innovative progress in preventing stillbirth and mitigating inequities. We also have a long
history of effective participation in research (e.g. NICHD Maternal-Fetal Medicine Units (MFMU) Network,
Stillbirth Collaborative Research Network, and Centers for Disease Control and Prevention), making UofU an
ideal research network center. In addition to being an exceptional center for the Consortium, we propose to
assess risk factors for adverse outcomes associated with decreased fetal movement (DFM). DFM is a major
risk factor for stillbirth, occurring in up to 50% of cases. However, it also occurs frequently in normal
pregnancies ending in live birth. Thus, risk stratification tools have great potential to improve stillbirth risk
detection. We also aim to assess and address disproportionate stillbirth burdens in AIAN and NHPI
communities. We will use audits to identify granular causes of and contributors to stillbirth through rigorous
cause of death audits and qualitative approaches. Further, we will qualitatively assess parental experiences
with stillbirth, related medical care, bereavement support, and evaluation for stillbirth. Disparities in these
communities are unacceptable and have not been previously studied in a rigorous fashion. The UofU’s ability
to support and complete Consortium research, in addition to our development of projects with high impact on
stillbirth prevention and support, will ultimately reduce stillbirths and improve health equity.

Public health relevance
PROJECT NARRATIVE The University of Utah’s Stillbirth Center of Excellence, community and global partners, and proposed studies on decreased fetal movement and stillbirth in Native American and Pacific Islander families will help the NICHD Consortium to reduce stillbirths and improve health equity.